Regulation of AP1 in response to glial cell compression

Project Summary/Abstract
Not Required for PA-23-189: Research Supplements to Promote Diversity in Health-Related Research (Admin
Supp Clinical Trial Not Allowed)

Public health relevance
Project Narrative Not Required for PA-23-189: Research Supplements to Promote Diversity in Health-Related Research (Admin Supp Clinical Trial Not Allowed)